RCMI@Morgan: Center for Urban Health Disparities Research and Innovation

PROJECT SUMMARY
The goal of this HIV/HCV/COVID-19 supplement project is to expand the original study cohort for studying (1)
the feasibility of and barriers to achieving HCV elimination among people living with HIV (PLWH) and people at
risk of HIV (PARH) through linkage to HIV care and prevention and (2) the impact of COVID-19 pandemic and
lockdown on HIV and HCV continuum of care and health outcomes. The original study cohort included HIV-
infected men engaged in HIV primary care at a large, multisite community health center from 2003 to 2014. In
this supplement project, we will expand the study cohort, from 2014 to 2024, and include additional minorities of
PLWH and PARH receiving HIV care or HIV pre-exposure prophylaxis (PrEP), respectively, at the clinics of this
community health center, such as women, transgender women/men, and rural dwellers. In addition, we will
extend the study sites to include a large multi-hospital healthcare system, with which my lab has established a
formal research partnership through the ongoing NIMHD-supported COVID-19 supplement project. The HIV
clinics of the community health center and the healthcare system are situated in urban and suburban Baltimore
and rural Maryland with major health disparities and provide HIV care and preventive services to people of racial,
sexual, and/or gender minorities and other socioeconomically disadvantaged populations. Based on the findings
from the original cohort, we hypothesize that (1) elimination of HCV health disparities and disease burdens could
be achieved for the PLWH and PARH by engaging in HIV care or preventive services, respectively, and (2)
certain circumstances and determinants could pose barriers to achieving this anticipated result. We will perform
a longitudinal retrospective cohort study with data derived from the medical records to assess various aspects
of HCV infection and care among the PLWH and PARH. First, we will determine trends and factors associated
with surveillance testing, prevalence, incidence, treatment initiation and completion, eradication, and re-
occurrence of viremic HCV among the PLWH and PARH. All of these HCV-related outcome measures (referred
as to the “HCV elimination package”) will be analyzed in the context of continuum of HIV care or PrEP usage
and other HIV-related virologic and immunologic parameters. Next, we will assess the HIV continuum of care
during the COVID-19 pandemic, analyzing the trends and factors associated with missing appointments, labs,
and/or prescriptions as well as utilization of telehealth for HIV care and preventive services. We will also examine
the HIV-related health outcomes among the PLWH and PARH prior to, during, and after the pandemic. Similarly,
each of the measures involved in the “HCV elimination package” will be assessed to determine the impact of
COVID-19 lockdown and HIV care/preventive service interruption on HCV elimination endeavours. Finally, we
will use the ongoing study cohort of >5,600 hospitalized COVID-19 patients in this multi-hospital health care
system to delineate the clinical features and determine factors associated with COVID-19 pathogenesis, disease
severity, and treatment outcomes among those with and without HIV and/or HCV coinfections.
PROJECT SUMMARY

Public health relevance
PROJECT NARRATIVE The goal of this project is to expand the original study cohort of HIV-infected men and include additional minorities (women, transgender women/men, and rural dwellers) of people living with HIV (PLWH) and people at risk of HIV (PARH) using HIV PrEP in the community-based primary care settings and assess the feasibility of and barriers to achieving elimination of HCV health disparities and disease burdens through linkage to HIV care and prevention among these diverse health disparities populations. We will study various outcome measures involved in HCV prevention, care, treatment, and cure in this expanded cohort of PLWH and PARH receiving HIV treatment or PrEP, respectively, and determine trends and factors associated with the prevalence and incidence of HCV acquisition, viremia, clearance, and re-infection. In addition, we will assess the impact of COVID-19 pandemic/lockdown on HIV and HCV continuum of care and related health outcomes using this new study cohort. PROJECT NARRATIVE